Census: 2000 and 2010 Modified Race Population Estimates

To develop an alternate series of intercensal estimates for the Hispanic population in the 4 bridged race groups: white, black, American Indian or Alaska Native, and Asian or Pacific Islander.